Adding spatial resolution and technical improvements to a novel single-cell DNA methylation sequencing technology

ABSTRACT
DNA methylation (DNAme) is a core layer of epigenetic regulation with central roles in the establishment and
maintenance of cellular identity. Methods to profile DNAme at single-cell resolution are needed to elucidate
epigenetic networks governing cell state in healthy tissues and understand their dysregulation in disease and
aging. However, existing methods for single-cell methylome profiling are highly inaccessible, and no methods to
experimentally profile both DNAme and spatial location currently exist. I have developed a novel method for
single-cell DNAme profiling that leverages the widely available 10x Single Cell Multiome and NEB EM-seq kits,
which I have named droplet-implemented single-cell DNA methylation sequencing (discDNAme). Applied to
nuclei isolated from mouse brain, discDNAme recovered ~3,000 high-quality methylomes that clustered into
clearly separated neuronal and non-neuronal subtypes and displayed stereotyped patterns of CpG dinucleotide
methylation around key genomic features. However, these measurements lack spatial information on the native
tissue contexts of profiled cells, and the protocol’s per-cell library size is lower than current gold-standard
methods for measuring single-cell DNAme. I propose (1) development of a spatially resolved single-cell DNA
methylation technology by combining discDNAme with slide-tags, a platform for spatially resolved single-nucleus
RNA- and/or ATAC-seq developed by our group. To integrate slide-tags with discDNAme, I will develop a
protocol in which the “spatial barcode oligos” we use to position nuclei are physically separated from genomic
DNA prior to unmethylated cytosine conversion, benchmark this technology in the mouse hippocampus, and
apply it to study glioblastoma multiforme. I further propose (2) experiments to improve and benchmark my
discDNAme technology. I will systematically test various independent approaches to increase library complexity
at different steps of the discDNAme protocol, combine these optimizations into a second-generation protocol,
and benchmark this against our original protocol and other leading methods for single-cell DNAme profiling.
Completion of this proposal will result in (1) the first high-resolution method to measure spatially resolved single-
cell methylomes—a major advancement in spatial omics technologies—and (2) an accessible yet capable tool
for single-cell DNAme profiling that will open single-cell DNAme studies to the broader single-cell community.

Public health relevance
PROJECT NARRATIVE Measurements of DNA methylation at single-cell resolution are essential for elucidating regulatory networks controlled by this core epigenetic layer within heterogeneous tissues, yet current methods are highly inaccessible and lose the spatial tissue context of profiled cells. I have developed a new approach to profile single-cell methylomes, named discDNAme, that is highly accessible and has immediately apparent avenues for improvement and extension. I propose integration of discDNAme with slide-tags to establish the first tool capable of spatially resolved single-cell DNA methylation profiling, and improvements to my protocol that increase library complexity to levels comparable to current state-of-the-art methods.